Achieving Optimal Sexual and Reproductive Health (SRWH Project)

Abstract
My Brother’s Keeper, Inc., and it partners, the University of Mississippi Medical
Center, the University of Southern Mississippi, and the Mississippi State Department of
Health, propose to implement the Achieving the Right to Optimal Sexual and
Reproductive Wellbeing Among Racial/Ethnic and Sexual/Gender Minorities in
Mississippi, The SRWB Project. The SRWB Project will be designed to address the
reproduced healthcare needs adults of reproductive age (18 to 45 years old) who
identify as racial/ethnic and sexual/gender minorities in the largely rural state of
Mississippi,
The project aims to end racialized prioritization of need in the state, and as such,
uses more complex markers of social vulnerability to identify priority areas in the state
where racial/ethnic and sexual/gender minorities are more vulnerable based on
comprehensive social and maternal vulnerability indices. Our approach, a community-
based participatory approach, ensures that the very lives we aim to improve have the
leading voice in prioritizing the structural factors that need to be addressed and the
health outcomes that need to be measured. The proposed project will potentially
address key structural factors related to the availability of non-discriminatory healthcare
services and resources. We will address two core areas including healthcare laws and
regulations, and organization environment. Access to safe, non-discriminatory care is a
key initial step to address reproductive and sexual health priorities, including maternal
health and HIV/STD incidence, in Mississippi.